EFFECTS OF EXOGENOUS SURFACTANT ON COLLOID OSMOTIC PRESSURE OF PREMATURE INFANTS

This study measures the effect of the administration of an exogenous surfactant on the colloid osmotic pressure in premature infants.